Middle East and North Africa Program forAdvanced Injury Research Training (MENA PAIR).

7. Project Summary / Abstract:
Despite the public health threat posed by trauma and injury in Low- and Middle-Income Countries (LMICs)
generally and in the Middle East and North Africa (MENA) in particular, there remains a large unmet need for
high-quality injury research in the region. The causes for this research gap are multifactorial but a major
component is a lack of trained researchers who can develop new lines of inquiry and have the skills to mentor
others to create teams of qualified injury researchers in the MENA region. The D43 parent award Yale-AUB
Middle East & North Africa Program for Advanced Injury Research (MENA PAIR) targets mutliple levels in
the injury ecosystem including: PhD level training to create leaders in injury research; Masters level training to
develop professionals to implement injury research and policy programs; Diploma training for clinicians to
augment research skills to conduct injury research; and workshop training in topics that target critical
stakeholders in the broader injury ecosystem involved in injury prevention and documentation (e.g., traffic
police, school nurses, sports coaches, caregivers). This supplement will augment and broaden the scope of
parent award Aims 1 & 2 by [AIM1] targeting a new level of trainee (junior faculty) for advanced research
skills development to help them more quickly become independent injury researchers; [AIM2] to provide faculty
level career development and research leadership training to develop injury research programs and lead teams
of future injury researchers being developed in our program; and [AIM3] improve diversity of clinical
research and research teams by supporting a female junior faculty member in trauma and injury research
training.

Public health relevance
Narrative The Middle East and North Africa (MENA) has rates of injury higher than the global average but has few public health professionals trained to conduct research in this area of public health importance. Our program seeks to train a diverse cadre of researchers to develop and lead trauma and injury that can inform policies and treatments to reduce the health burden from injuries in the MENA region.